Investigating cell-type specific convergence of APOE and ABCA7 lipid dysregulation in Alzheimer’s disease

Project Summary/Abstract
Alzheimer’s disease (AD) is a progressive and fatal disorder characterized by memory loss and
cognitive decline. It accounts for 60-80% of dementia cases and affects more than 20% of
people over age 75. Several genetic risk factors have been identified, yet mechanisms linking
them to AD onset, progression, or severity are still largely unknown. Therapeutic interventions,
which have focused on improving pathological hallmarks of AD such as amyloid accumulation,
have had only limited success, suggesting the need to identify new approaches. Lipid
dysregulation has long been known to be important in AD, and damage to the lipid-rich myelin in
white brain matter is emerging as a key pathology, pointing to the importance of lipid-related
pathways as potential drug targets. However, studies of the mechanisms underlying lipid
dysregulation in AD have been limited. This project seeks to identify commonalities in how AD
risk variants in two different lipid-associated proteins, the lipid carrier ApoE and the trans-
membrane lipid transporter ABCA7, lead to lipid dysregulation in oligodendroglia, the cells
responsible for creating and maintaining the myelin sheath around neuronal axons. Single-cell
RNAseq data from post-mortem brain samples will be used to identify transcriptional signatures
that are present both in samples with the APOE4 variant and in samples with loss-of-function
(LoF) variants in ABCA7 to reveal key lipid-related pathways that are perturbed by risk variants
in either protein. The molecular and functional consequences of these pathway perturbations
will then be explored in-depth in models based on induced pluripotent stem cells (iPSC)
containing these risk variants. Co-culture systems of iPSC-derived oligodendrolia (iOG) and
neurons (iN) have been shown to achieve axonal myelination and thus represent a fully
tractable and modular model of neuron-oligodendrocyte interaction and oligodendrocyte
functionality. The specific aims are (1) to characterize the lipid dysregulation and its underlying
causes in iOG bearing the APOE4 variant or LoF variants in ABCA7; (2) to characterize the
impact of the APOE4 variant or LoF variants in ABCA7 on myelination in iOG-iN co-cultures and
to determine if the variant effects can be rescued by pharmacological intervention; in addition,
targeted disruption of individual genes within the dysregulated pathways will be used to identify
key regulatory genes involved in the variant effects; (3) to investigate if the transcriptional
signatures found in samples with APOE4 or LoF variants in ABCA7 are also present in AD post-
mortem brain samples that are non-carriers for APOE4 or ABCA7 LoF or bear other risk
variants implicated in lipid metabolism, potentially identifying a sub-category of AD.

Public health relevance
Project Narrative Alzheimer’s disease (AD) has been associated with lipid dysregulation and with de-myelination in the brain white matter, and this project seeks to gain a mechanistic understanding of lipid dysregulation, specifically cholesterol dysregulation, in the brain cells responsible for myelination (oligodendrocytes). Key cellular pathways will be identified by studying the intersection of how AD risk variants in the lipid carrier ApoE and the lipid transporter ABCA7 lead to lipid dysregulation in oligodendrocytes, and a common transcriptional signature for lipid dysregulation will be defined. By testing for presence of this transcriptional signature in post-mortem brain samples from AD patients with other AD risk variants, the project aims to identify a sub-category of AD that could inform treatment choice.